Building Healthy Eating and Self-Esteem Together for University Students (BEST-U): A Pilot Randomized Controlled Trial of an mHealth Intervention for Binge-Spectrum Disorders

PROJECT SUMMARY/ABSTRACT
Eating disorders (EDs) are a critical concern on college campuses. Moreover, since the COVID-19 pandemic,
ED prevalence has increased by 62% in university women and 140% in university men. Resources are
inadequate to meet demand, leading to delays in students’ access to treatment. Untreated (or poorly treated)
EDs result in greater healthcare utilization and costs to students, as well as lower academic achievement and
increased psychiatric disability and mortality, suggesting a critical need for quality ED treatment on university
campuses and to rethink treatment delivery. One way to address this gap in care delivery is to improve
treatment accessibility and scalability, such as dissemination via mobile apps. Guided self-help Cognitive-
Behavior Therapy (CBT-gsh) is a cost-effective option that can be delivered by non-traditional service
providers, such as nurses and physicians. Our scientific premise is that the mHealth CBT-gsh app, Building
Healthy Eating and Self-Esteem Together for University Students (BEST-U), will lead to reductions in binge
eating (primary outcome) through reductions in dietary restraint and weight/shape concerns (target
mechanisms). Our pilot data showed strong support for our premise, specifically the need for brief, targeted
mHealth interventions in students and the ability of the program to significantly reduce binge eating and
impairment and increase wellbeing, with high user acceptability and low drop-out rates. However, prior to
implementing BEST-U at other universities, we need to test the intervention in a real-world setting with the end
goal of disseminating at scale. Our objectives are to: 1) conduct an effectiveness test of BEST-U compared to
a similar dose of present-centered therapy (PCT) in students with non-low weight binge-spectrum EDs and 2)
test target mechanisms that lead to changes in binge eating. To accomplish our objectives, we will test the
following specific aims: 1) conduct an RCT of BEST-U (N=47) compared to a similar dose of PCT (N=47) in
students with non-low weight binge-spectrum EDs; 2) test target mechanisms that lead to changes in binge
eating and other ED symptoms; and 3) characterize barriers and facilitators to implementation across two
campuses. Our exploratory aim will test food reinforcement and food-choice impulsivity as potential target
mechanisms or response moderators of rapid response in binge eating. Given the rapidly rising rates of EDs
and the lack of existing treatment resources, the proposed study is innovative and significant because it will
provide a scalable treatment to fill gaps in care to promote student wellness and educational attainment. Our
pilot data showed initial efficacy for BEST-U, yet the proposed study is necessary to validate the treatment in a
student health setting prior to large-scale dissemination. Furthermore, given that few studies have identified
underlying mechanisms that explain how CBT-gsh works and for whom, this study may lead to improved ability
to tailor or modify existing CBT-gsh (e.g., personalized medicine approaches) or lead to novel intervention
development for students who are unlikely to respond rapidly (or at all) to first-line CBT interventions for EDs.

Public health relevance
PROJECT NARRATIVE EDs are common mental-health conditions on university campuses, yet resources are inadequate to meet demand, leading to delays in students’ access to treatment. Untreated (or poorly treated) EDs result in greater healthcare utilization and costs to students, as well as lower academic achievement and increased psychiatric disability and mortality, suggesting a critical need for quality ED treatment on university campuses and to rethink treatment delivery. The proposed research is, thus, relevant to public health because it will result in an evidence-based mHealth app for EDs that can be delivered by non-traditional mental-health providers in student healthcare settings, which will address an important and largely unmet mental-health need on university campuses. The proposed research is relevant to the NIH’s mission to tailor existing interventions to optimize outcomes and to test interventions for effectiveness in community- practice settings (see NIMH’s Goal 3: Strive for Prevention and Cures).